Development and Feasibility Trial of Online Peer Support for Parents of Gender Diverse Youth

ABSTRACT
Gender diverse youth (GDY) are those with incongruence between their gender identity and sex assigned at
birth. This population faces significant mental health inequities compared to cisgender (not gender diverse)
youth, including increased rates of depression and suicidal ideation. Research suggests that parent affirmation,
or parents supporting their child’s gender identity, can reduce these health inequities, but there are no evidence-
based strategies to help parents affirm their GDY. Being affirming can be challenging for parents, and current
literature indicates that both external experiences, like connectedness and discrimination, and internal
experiences, like fear and stigma, may shape these challenges. Further, there are limitations to existing support
systems for parents including geographical considerations, as most groups or opportunities to meet are in urban
centers, and social pressure, as many parents feel overwhelmed in large group settings. Online support
programs have the potential to overcome these barriers and allow for 1:1 parent peer mentoring, which has
shown success in other pediatric patient populations as well as potential for GDY and their families. However,
there is a need for increased stakeholder-engaged research to understand parent factors associated with being
affirming. Such data are needed to develop acceptable and feasible online support programs that are effective
at aiding parents to affirm GDY. The central hypothesis of this research is that an online 1:1 parent peer support
program will lead to increased parent affirmation and improved health outcomes for GDY. This K23 project will:
1) survey a geographically and racially diverse cross-section of parents of GDY in the United States to better
understand factors associated with being affirming, 2) design a stakeholder-informed online support intervention
featuring 1:1 parent peer mentoring for parents of GDY, and 3) pilot test the online support intervention for
feasibility and acceptability. Conduct of these aims, in addition to a career development plan inclusive of
coursework, workshops, and leadership development, will allow for the applicant’s academic growth in nationally
representative surveys, stakeholder-engaged intervention development, clinical trials, and research program
leadership, and will further advance the applicant’s transition to independence. These aims also will provide the
necessary data to conduct a future R01 randomized control trial to evaluate the effectiveness of the stakeholder-
designed online 1:1 parent peer mentoring intervention to improve parent affirmation of GDY, ultimately helping
to improve health equity for this vulnerable population.

Public health relevance
PROJECT NARRATIVE At risk youth (ARY) are those who are at risk of suicide and self-harm with suicide being the second highest cause of death in adolescents. Little is known about the experiences and needs of parents of this population of vulnerable youth. Parent support is recognized as an important factor in protecting ARY from self-harm and suicide, but there are few evidence-based support programs for parents of ARY. This study will survey a cross-section of parents about their experiences and will develop an online intervention that connects them with other parents for mentored peer support. By assessing feasibility and acceptability of the new parent support intervention, this work will inform future research aimed at improving health outcomes for ARY.